Organizational Capabilities

The Cancer Therapy & Research Center (CTRC) is a matrix based Cancer Center of the University of Texas Health Science Center at San Antonio (UTHSCSA). The CTRC's organizational structure includes: